The Impact of Social Rejection: Investigating Pain-related Stigma in Adolescents with Chronic Widespread Musculoskeletal Pain

ABSTRACT
Pain-related stigma is a significant and understudied psychosocial factor among adolescents with chronic
amplified musculoskeletal pain (CMP), which includes chronic widespread musculoskeletal pain (CWMP) that
has been implicated in impaired health outcomes. The subjectivity of pain self-report increases the opportunity
for an individual to experience symptom disbelief by others. Pain-related stigma is a significant public-health
priority due to its potential impact on delayed diagnosis and impairment in recovery. Adolescents with CMP are
vulnerable to pain-related stigma from several sources, including physicians, school staff, family, and peers,
likely impacting their health. The objectives of this proposal are to: 1) examine how pain-related stigma is a
novel and necessary psychosocial component of adolescent CMP, and 2) develop and validate the Pain-
Related Stigma Scale for Adolescents (PReSS-A) in patients with CMP. Not enough is known about pain-
related stigma in this young population. This proposal uses a mixed-methods design to develop a theoretical
framework in new areas of psychosocial research for adolescents with CMP. This research will provide a
foundation for understanding pain-related stigma and developing interventions to target this social construct in
adolescents with CMP. The specific aims are: 1) develop a pain-related stigma framework and PReSS-A items
using separate focus groups of adolescents with CMP and juvenile idiopathic arthritis (JIA) and their parents;
2) refine PReSS-A items using classical item analyses in a sample of adolescents with CMP; 3) validate final
PReSS-A items in a larger sample of adolescents with CMP, and test construct validity using a comparative
sample of adolescents with JIA, who are hypothesized to report less stigma due to the medical evidence
supporting their JIA diagnosis; and 4) leverage structural equation modeling to explore relationships between
perceived pain-related stigma and psychosocial and health outcomes. The use of multiple patient populations
(i.e., CMP and JIA) and their parents to examine and validate a measure of this social construct is innovative.
This career-development award is designed to allow Dr. Emily Wakefield, a pediatric psychologist in the
Division of Pain and Palliative Medicine at Connecticut Children's Medical Center and Assistant Professor of
Pediatrics at the University of Connecticut School of Medicine, to become an independent researcher
dedicated to improving health outcomes for adolescents with chronic pain. Her short-term goal is to understand
mechanisms contributing to pain-related stigma and develop interventions focused on reducing this stigma in
adolescents with CMP. Her long-term goals are to be a national leader in psychosocial research on pediatric
chronic pain and an expert on adolescent pain-related psychosocial health outcomes. The objectives of this
bioethics supplement are to build the research capacity of pain-related stigma research by enhancing the racial
diversity of participants via (1) identifying barriers to pain treatment equity for racialized youth with CMP, and
(2) develop solutions to overcome these obstacles via the development of a Diversity Task Force.

Public health relevance
PROJECT NARRATIVE – No Changes From The Original Application Pain-related stigma is a significant and understudied psychosocial factor among adolescents with chronic widespread musculoskeletal pain (CWMP), that has been implicated in impairment in health outcomes and quality of life. This project aims to: 1) develop a novel pain-related stigma framework that is useful in assessing outcomes in adolescent CWMP; and 2) develop and validate the Pain-Related Stigma Scale for Adolescents with CWMP (PReSS-A). This study will lay the foundation for understanding pain-related stigma and developing clinical interventions that will target social factors and improve health outcomes in this population.